Evaluating Mechanisms Underlying Resistance in Alzheimer’s Disease

PROJECT SUMMARY
Alzheimer disease (AD) is the most prevalent neurodegenerative disorder, affecting over 50
million people worldwide. Age and genetic variation can place individuals at high risk for
developing AD, yet a unique subset of people at higher risk resist pathology and do not develop
disease. Recent reports implicate the glymphatic system and corpora amylacea (CA) in the
clearance of brain waste products. Corpora Amylacea amass cellular debris such as proteins and
extrude them into the CSF where they travel to the cervical lymph nodes and are phagocytosed.
The proper functioning of CA may play a role in AD resistance, and might be influenced by age,
degree of pathology, and genetic risk. Understanding the brain’s innate response to toxic protein
aggregates is essential for a deeper understanding of the development of AD pathology and
potentially identifying disease biomarkers. Here we investigate whether CA contribute to
resistance to AD pathology by quantifying CA location and number in the hippocampus of post-
mortem AD and control brains. To evaluate the mechanisms underlying resistance we aim the
answer the following questions: 1) Is clearance of intracellular pTau by CA associated with
resistance to AD pathology? 2) In individuals who develop AD-related tau pathology, do CA,
genetics, and vascular pathology influence the density of tau accumulation and the distribution
across the hippocampus? Answering these questions will identify and quantify novel contributions
to resistance of AD in the presence of elevated risk. This fellowship project proposal offers the
opportunity to train in computational neuroscience and genetic epidemiology.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease and other tauopathies are the primary causes of dementia in older adults. This project will explore why some adults seem to be resistant to AD-associated pathological changes in the brain despite carrying genetic risk factors for AD. We propose that dysfunction of a cell component called Corpora amylacea may contribute to buildup of AD-associated proteins in the cell. The proposed studies are essential to further understand the clinical-pathological- genomic relationship and provides the applicant broad training in computational neuroscience and genetic epidemiology.